MYCOPLASMA STUDIES ON RHEUMATOID ARTHRITIS AND SCHIZOPHRENIA

Using 12 different and elaborate broth, agar and cell culture procedures, we failed to isolate either mycoplasmas, ureaplasmas, spiroplasmas or chlamydiae from the synovial fluids of ten rheumatoid arthritis {RA} and six non-rheumatoid arthritis {NRA} patients. In addition, 35 RA and 12 NRA sera were also examined. Although some of the sera had moderately high metabolism inhibition antibody titers to some of the ten human Mycoplasma species, especially M. pneumoniae, a ommon respiratory pathogen, and to some of the eight U. urealyticum serovars, especially serovars V and VII, there were no significant differences in the two patient groups to these agents. Five RA patients had serum titers of 1:32 and eight had titers of 1:16 to M. pneumoniae and two patients had higher titers in their synovial fluids {1:16} than in sera {1:4}. Two RA patients had moderately high serum titers of 1:32 and 1:128 to U. urealyticum serovar V and ten RA patients had relatively high titers of from 1:32 to 1:512 to serovar VII. The GMT titer to serovar V in synovial fluids of RA patients was higher, but not quite significantly different from that of NRA patients {p.0.056]. However, RA patients had low, but significantly higher GMT titers to Spiroplasma mirum, SMCA, a mycoplasma isolated from a rabbit tick, in both their serum {p.0.016} and synovial fluids {p.0.023} than did NRA patients, but the nature of the inhibition was not determined. Reports on the possible role of infectious agents in the pathogeneses of rheumatoid arthritis are reviewed.